Movement Amplification Gait Training to Enhance Walking Balance Post-Stroke

Background: There is a pressing need to develop effective methods to enhance walking balance in people with
chronic stroke (PwCS). Interventions that amplify self-generated movements may accelerate motor learning by
enhancing a person's perception of movement errors. This method could potentially be applied to help PwCS
improve walking balance. To this end, we have developed a cable-driven robot to create a Movement
Amplification Environment (MAE) during treadmill walking. The MAE challenges walking balance by applying
lateral forces to the pelvis that are proportional in magnitude to real-time lateral center of mass (COM) velocity.
Unlike a popular form of balance training that uses unpredictable perturbations to enhance reactive balance,
training in a MAE targets anticipatory balance by developing predictive control mechanisms that are likely to
persist when the training environment is removed (after-effects). We believe that supplementing high-intensity
gait training (the recommended practice to improve walking speed and distance) with a MAE will substantially
enhance walking balance. Thus, our purpose is to evaluate the unique effects of MAE training on walking balance
in PwCS and determine feasibility of conducting high-intensity gait training in a MAE.
Specific Aims: Aim 1: To evaluate gait patterns PwCS adapt during and immediately following walking practiced
in two balance-challenging training environments: MAE and unpredictable lateral perturbations. Aim 2: To
establish feasibility of high intensity gait training in MAE we will evaluate cardiovascular intensity during gait
training interventions performed in either a natural unmodified environment or a MAE.
Approach: Aims 1: 15 PwCS will participate in a single-day experiment evaluating gait biomechanics (COM
dynamics and stepping patterns) during and immediately following treadmill walking performed in a MAE or while
receiving frequent unpredictable lateral perturbations. Outcomes will assess if changes in gait patterns to
maintain stability persist immediately following exposure to either of the balance-challenging environments. Aim
2: 15 PwCS will participate in two high-intensity gait training sessions. One session will be performed in a natural
unmodified environment, the other in a MAE. We will quantify differences in mean heart rate (HR) between the
two sessions and whether mean HR is in the target high-intensity range of 70-85% of maximum HR.
Impact: This project will identify if and how PwCS uniquely adapt locomotor strategies following exposure to
balance challenging environments and evaluate feasibility of administering high-intensity gait training in a MAE.
Training walking balance of PwCS in a MAE by amplifying their own self-generated movements is a radical
departure from current practice and could substantially enhance walking balance. Successful outcomes will
motivate a future randomized controlled trial assessing the efficacy of MAE training to enhance walking balance
in PwCS.

Public health relevance
Stroke is a leading cause of disability in the United States, affecting ~795,000 people annually. The Veteran's Health Administration provides over 60,000 outpatient visits for stroke-related care annually at a cost of over $250 million. Among ambulatory people with chronic stroke (PwCS), impaired balance is a common health concern that substantially limits mobility (those with the worst balance walk the least). This project will explore adaptive strategies employed by PwCS in balance challenging environments and if a novel gait training intervention using a robotic device to amplify a person's self-generated movements can improve walking balance. The development of effective interventions to increase walking balance among PwCS will positively impact Veterans' health, quality of life, and ability to participate in walking activities.